COVID-19: NIAID CLINICAL SITE MONITORING

The purpose of the Clinical Site Monitoring contract is to provide comprehensive clinical site and study monitoring services for the NIAID clinical trial research portfolio, including the delivery of monitoring services for unanticipated NIAID clinical research projects that may be required in response to emerging needs or public health emergencies. This project will provide clinical trial monitoring services for the COVID-19 clinical trial ACTIV-2 (Outpatient Monoclonal Antibodies And Other Therapies).